Context dependent amino acid availability and sensing determines humoral immunity

Project Summary
Amino acids are crucial nutrients that are also important to support immunity. Yet, we have limited
understanding with regard to how immune challenges modulate amino acid availability, and how immune cells
sense amino acid and transduce the signals to execute immune reponses. Rag-GTPase has recently been
identified as a key amino acid sensor that mostly transduce signals from amino acids to mechanistic target of
rapamycin (mTOR) complex 1 (mTORC1) in non-hematopoietic cells. However, Rag-GTPase also modulates
transcription factor TFEB, a member of the microphthalmia (MiT/TFE) family of HLH-leucine zipper
transcription factors, whose functions in B cells remain unknown. Moreover, Rag-GTPase independent
mTORC1 activation has been identified. How Rag-GTPase and mTORC1 coordinates to regulate humoral
immunity has not been addressed. We compared the functions of Rag-GTPase and mTORC1 in B cell
response in vivo using genetic knockout models. Our data showed that while both Rag-GTPase and mTORC1
are required for systemic immune challenges, Rag-GTPase, but not mTORC1, is critical for humoral immune
response towards respiratory influenza infection. This divergent requirement between Rag-GTPase and
mTORC1 is associated with differential amino acid availability between systemic immunization and airway
influenza infection. Furthermore, we showed that Rag-GTPase suppresses TFEB and promotes autophagy,
which is associated with ERK activation, but largely independent of mTORC1. Thus, we hypothesize that
reduced availability of specific amino acids during respiratory viral infection renders B cells dependent on Rag-
GTPase-TFEB pathway, for GC reaction and anti-influenza antibody production. In Aim 1, we will first test
whether the respiratory route of live virus immune challenge is the determining factor for Rag-GTPase
dependent, but mTORC1 independent, humoral immunity. Second, we will further investigate the temporal and
spatial dynamics of amino acid availability during immune challenges. Finally, we will test whether dietary
amino acid intervention can improve humoral immunity against respiratory viral infection. In Aim 2, we will
utilize complementary loss-of-function and gain-of-function approaches to elucidate the downstream signaling
mechanisms by which Rag-GTPase promotes GC reaction and humoral immunity. We will further characterize
the Rag-GTPase interactome in B cells using unbiased proteomics approach. Our study will define a novel
Rag-GTPase-ERK-TFEB signaling axis that respond to amino acid availability to promote B cell activation and
antibody production against airway viral infection.

Public health relevance
Project Narrative Immune cells can sense the changing levels of proteins and produce antibodies to protect host from virus infection. This response involves a complex network of signaling molecules. We aim to understand how this signaling network is organized to respond to the changing concentration of proteins so that we can design better strategies to improve immune defense against virus infection.